Training in Tropical and Emerging Global Diseases

The Training in Tropical and Emerging Global Diseases (TTEGD) program at the University of Georgia
(UGA) trains graduate students and postdoctoral scholars to become independent research scientists
who study parasitic diseases in the context of global health. The research program seeks fundamental
insights into protozoan and helminth parasites and their interaction with their mammalian hosts and
invertebrate vectors. It combines cutting-edge bench and field science with perspectives on the global
challenges and opportunities for the control and elimination of parasitic diseases. These perspectives
are grounded in firsthand experience by trainers and collaborators around the world. Every year
protozoan and helminth parasitic diseases of humans are responsible for more than a million deaths,
many millions more cases of severe morbidity, and hundreds of millions of cases of subtle morbidity
due to chronic infections. UGA is uniquely positioned as a training ground for the next generation of
parasitology/tropical disease researchers and the TTEGD is the central basis of their training and
development. The Center for Tropical and Emerging Global Diseases (CTEGD) within UGA is home to
perhaps the largest number of parasitology research laboratories in the US that collectively cover the
full gamut of parasitic diseases. We believe that the breadth and culture of our program instill trainees
with the ability to translate basic scientific findings into tool development and the implementation of
interventions, and foster their ability to identify and formulate a fundamental research question out of
the context of parasitic disease itself. During the last funding period, the program has further grown and
flourished and selected students and postdocs participate in a number of activities tailored to their
preparation for their future success in science careers. Significant institutional commitment for breadth-
enhancing capstone experiences, a match for trainee lines, a reorganized innovative graduate
recruitment umbrella, and new diversity initiatives further strengthen this highly successful training
program. For the next funding period we introduce new initiatives including new requirements for
postdoc trainees, a more rigorous training of new trainers, new postdoc recruitment strategies to
increase diversity, new strategies to recruit underrepresented minorities, potential expansion of the
program with the use of matched trainee lines and new themes offered to trainees on large data mining
and computer science.

Public health relevance
Parasitic diseases are responsible for millions of deaths in addition to severe and subtly morbidity and there are no effective vaccines or drug treatments to combat them. Understanding how parasites cause disease requires researchers and practitioners with high level of training. The Training in Tropical and Emerging Global Diseases program offers advanced training and professional development of talented predoctoral and postdoctoral trainees to prepare them for careers dedicated to fighting parasite pathogens.